Administrative Core

The goals of the Administrative Core are to provide: 1) leadership for the REACH research base; 2)
administrative management, fiscal oversight, and reporting all REACH activities; 3) coordination and integration
of REACH communications; and 4) management of the Enrichment Program, including seminars, workshops,
symposia, retreats and the Pilot/Ancillary grant program program. The Administrative Core will be led by a
Director (Lotz) and Operations Director (Coughlin) who are assisted by an Internal Executive Committee, an
Internal Advisory Committee, and an External Advisory Committee.

Public health relevance
Per RFA, Project Narrative is not required.